Gut Microbiota, Metabolic Disorders and Beyond

? DESCRIPTION (provided by applicant): Support is requested for a Keystone Symposia meeting entitled Gut Microbiota, Metabolic Disorders and Beyond, organized by Rémy G. Burcelin, Sven Pettersson and Tak W. Mak. The meeting will be held in Newport, Rhode Island from April 17-21, 2016. The hologenome theory of evolution proposes that natural selection acts not on the individual organism but rather on the holobiont, which consists of the organism together with microbiome (its genes and metabolites). When a holobiont is challenged by dramatic changes, such as altered diet or reduced physical activity, it employs adaptive mechanisms in the form of reshuffling its microbiome (resident microbial communities). However, the underlying mechanisms of molecular crosstalk remain to be determined. Effective study of the holobiont requires a systems biology approach: remove one component of the holobiont to study it in reductionist style and other parts also altered will be overlooked. Decades of reductionist research aimed at understanding the mechanisms responsible for the current dramatic epidemic of man-made metabolic diseases have not considered the holobiont perspective and have consequently missed the adaptation strategies of the microbiome but have set the stage to explore the inchoate holobiont perspective. Application of a systems biology approach to decipher molecular mechanisms underlying man-made metabolic diseases presents a unique opportunity to develop novel therapies that sustain health in a personalized manner. This meeting will discuss how the gut microbiome and its metabolites influence major molecular and physiological mechanisms responsible for man-made metabolic diseases. It will therefore incorporate investigators from diverse areas such as medicine, immunology, neurobiology, endocrinology, physiology, psychiatry, systems biology and microbiology. In addition, the nutritional, surgical and pharmacological aspects of innovative therapeutic strategies will be discussed in dialogue with scientists from pharmaceutical/nutritional companies. The gut microbiome is a neuroendocrine and antigenic organ whose rediscovery is necessary for our understanding of man-made metabolic diseases in the context of the holobiont.

Public health relevance
PUBLIC HEALTH RELEVANCE Metabolic disease remains a major leading cause of death in the United States and a leading cause of mortality worldwide. Despite intensive research, effective treatment for most metabolic diseases remains to be identified. Over the last decade new opportunities have emerged as we have learned more about the role of gut microbiota. The Keystone Symposia meeting on Gut Microbiota, Metabolic Disorders and Beyond will bring together researchers focused on gut microbiota ecology, cell biology, pre- and probiotic therapies, and pharmaceutical development to exchange perspectives, to better understand the nature of the challenge that gut microbiota present for metabolic disease, and to foster new therapeutic progress.